Administrative Core

ABSTRACT
This U19 consortium grant is an interdisciplinary, multi-investigator research program that requires a well-
organized, and efficient Administrative Core to ensure its success. Dr. Chao will serve as the primary leader of
the Administrative Core. He will assisted by Dr. David Kirsch who will act as the core co-leader. The overall
goal for this core is to create and implement administrative and leadership mechanisms. These mechanisms will
foster effective interactions amongst the program investigators to ensure a productive research effort and to
ensure proper regulatory, financial and reporting standards. To accomplish our goal, the administrative core will
be responsible for the overall organization, management, decision-making, communications, and periodic
evaluations within the program. The administrative core will be responsible for data sharing oversight, protection
of intellectual property, and involvement of institutional resources. This Core will also organize and support the
activities of the internal steering committee and the External Scientific Advisory Committee. The specific aims
for the administrative core are: Aim 1: Provide overall strategic leadership and direction that affords opportunities
for collaboration. Aim 2: Ensure maintenance of scientific rigor and milestones of project and core. Aim 3:
Provide financial management for each project and core. Aim 4: Manage internal and external communications
for the program.

Public health relevance
Narrative: This multi-project program will develop medical treatments for people exposed to radiation.